Chlamydia trachomatis modulation of host inflammasome

Chlamydia trachomatis is the leading cause of sexually transmitted infections worldwide with
approximately 90 million new cases reported annually. Complications to infection in women
include pelvic inflammatory disease, ectopic pregnancy and increased risk of cervical cancer.
Despite these significant medical concerns there are fundamental gaps in our understanding of
Chlamydia pathogenesis, particularly with regards to the host immune response and
inflammasome activation. C. trachomatis is known to stimulate IL-1beta secretion and activate
the NLRP3 inflammasome but the mechanism of modulation is not known. Our strong preliminary
data demonstrates that a Chlamydial protein, CT226, interacts with Leucine Rich Repeat Protein
1 (LRRFIP1), and Flightless 1 (FLII), upstream regulators of the NLRP3 inflammasome. We
hypothesize that this interaction between CT226 and LRRFIP1/FLII modulates
inflammasome activation during C. trachomatis infection. With the latest innovative genetic
tools and transformation methods, we have generated a CT226 deletion strain of C. trachomatis.
The CT226 deletion mutant will be assessed for differences in inflammasome activation, secretion
of 1L-1beta, IL-18 and caspase 1 activation. Using siRNA depletion and inflammasome deficient
cell lines we will assess the role of inflammasome activation on C. trachomatis replication,
infectivity and intracellular survival. The proposed research is critical to understanding the role
inclusion membrane proteins have in host immune response during C. trachomatis infections and
will address a key fundamental knowledge gap regarding Chlamydia modulation of inflammasome
activation.

Public health relevance
Project narrative/relevance Chlamydia trachomatis is a well-known sexually transmitted bacteria that causes millions of infections in the United States and worldwide yearly. This pathogen is very versatile and manipulates host immune response during infection. This research will increase our knowledge on how the bacteria manipulates the inflammasome and host immune responses after infection is initiated.